UIC Diabetes Research Training Program

Summary
Diabetes mellitus is a major cause of morbidity and mortality in the United States and training
the next generation of researchers is essential for developing new strategies to prevent and
improve the treatment of diabetes. This T32 program will provide closely mentored,
individualized, in-depth training in an interactive and supportive, multidisciplinary environment
that fosters collaboration between disciplines and strongly promotes recruitment and retention
of underrepresented minorities at the University of Illinois at Chicago (UIC). The largest
university in the Chicago area with annual research expenditures of approximately $335 million,
and recognized as a Minority and Hispanic Serving Institution, UIC provides outstanding
opportunities for training in basic, clinical, translational, and behavioral and community-based
research targeting diabetes and access to cutting edge technologies. PhD, MD and trainees in
other clinical disciplines will be highly selected based on demonstrated research interest,
accomplishments and potential, engagement in research, and the accomplishment of milestones
(identification of research mentors, preparation of a preliminary project proposal and IDP) will
be required prior to joining the T32 program. Individualized training and career development
plans are developed at the outset with input from multidisciplinary mentoring teams that identify
appropriate goals, needs and milestones. Trainees will receive training in grant writing, research
integrity and ethics and methods to enhance research reproducibility, and participate in research
seminars, journal clubs and work-in-progress meetings, and, when appropriate, complete
graduate level courses pertinent to their research and career goals, including degree conferring
programs at the Masters level (e.g. MS in Clinical and Translational Science, Health Informatics,
etc). The development and submission of an individual NRSA or other career development
application will be a major goal and training experience during the T32. The progress of trainees
will be closely monitored and feedback from trainees on mentoring and the research program
reviewed annually. Additional oversite and guidance will be provided by Internal and External
Advisory Committees. The success of this program will be evaluated based on the research and
academic success of its trainees. This program is designed to provide outstanding training in
research related to diabetes in a vibrant, diverse and scientifically responsible environment at a
major research institution in Chicago.

Public health relevance
Project Narrative Diabetes mellitus is a major cause of morbidity and mortality in the United States and research by a new generation of investigators is required to more effectively prevent and treat diabetes. This program will provide intensive post-doctoral training in diabetes research for MD and PhD trainees in a highly collaborative, multidisciplinary environment that promotes diversity at the University of Illinois at Chicago, the largest university in the Chicago area.